Cancer Center Administration

The University of Michigan (U-M) Rogel Cancer Center (Rogel) Administration provides fundamental resources
and support to the Center and Rogel senior leadership to achieve its mission to reduce the burden of cancer
and advance health access through transdisciplinary collaboration in research, education, patient care and
community outreach. The vision of the Center is to be a leader in prevention, early diagnosis, optimal treatment
and care for all with higher probability of, or affected by, cancer. This is accomplished through an efficient
infrastructure that facilitates timely and value-added assistance to cancer center senior leaders and members
to achieve the 2022-2027 Strategic Plan – Discoveries to Cures to Communities. Rogel Administration adds
value to the six Rogel Research Programs, 13 (and two developing) Shared Resources (SRs), Community
Outreach and Engagement, Training, Education and Career Development, and clinical research by ensuring
infrastructure and resources are in place to accomplish strategic priorities and goals. Rogel Administration
partners closely with leadership to foster collaborative research through inter- and intraprogrammatic meetings
and retreats, 18 working groups, team science pilot projects, and multidisciplinary committees and advisory
boards. Rogel Administration provides essential support to execute all governance, planning, evaluation,
space, and resource allocation functions for the Center, including: i) Realignment of Research Programs in
response to feedback from the External Advisory Board (EAB) and in-depth evaluation of program aims,
membership and metrics; ii) Establishment of two new SRs and launch two developing SRs; iii) Implementation
and evaluation of the prior strategic plan and development a new five-year plan; and iv) Establishment of key
leadership appointments and multi-year investments in clinical research and cancer control and population
sciences to enhance these mission critical areas. Administration oversees membership and research
administration functions members across 54 departments and nine U-M schools and colleges, with over 100
members recruited in the last five years. Rogel Administration advances the naturally interactive and
collaborative cross-disciplinary research environment and facilitates high-impact laboratory, clinical, and
population science discoveries.